CORE--FLOW CYTOMETRY FACILITY

To provide participants in the lymphocyte biology program project complete flow cytometric services. This will include sorting and analyses of immunofluorescence (up to 3 colors), forward and narrow-angle light scatter, cell diameter (axial pulse width), membrane potential, cell cycle, and intracellular free calcium levels.